Dyadic yoga Program for Patients with Lung Cancer Undergoing Radiotherapy and their Family Caregivers

PROJECT SUMMARY/ABSTRACT
Patients with lung cancer, the most prevalent cancer in United States affecting both men and women, experience
more debilitating physical and psychological symptoms than patients with other types of cancer. Common
symptoms include reduced lung function, dyspnea, fatigue, sleep disturbances, and depression compromising
their quality of life (QOL). In light of these symptoms, patients have a high need for care and support. Patients’
family caregivers are their most important and valued source of support and care; yet, caregiving is physically
and emotionally taxing. In fact, family caregivers report high rates of psychological distress, fatigue, and sleep
disturbances, which may compromise the quality of care they are able to provide to the patient. Given the
interdependent nature of QOL in families, poor caregiver QOL may undermine patient QOL. Therefore, there is
a need to established evidence-based dyadic supportive care programs targeting both patient and caregiver
outcomes. Based on the promising findings of our pilot data, we proposed to examine a dyadic yoga program
in patients with lung cancer (LC) and their family caregivers. To determine efficacy of a yoga program, the
proposed research will randomly assign patient-caregiver dyads to either a dyadic yoga or a dyadic education
group. Prior to randomization, both patients and caregivers will complete standard QOL measures. We will also
collect biomarkers from blood and saliva samples. Patients will complete objective measures of physical
performance. Based on their group assignment, dyads will either attend yoga sessions or health education
sessions together. Both groups will receive the same intervention exposure (15 sessions, 60 min each) over the
course of patients’ 6-week radiation treatment (RT) plans. During the treatment period, we will weekly assess
patients’ symptoms. At the end of RT, 1, 2, 3, and 6-months later, dyads in both groups will be re-assessed. At
the 3-month follow-up assessment, we will also collect qualitative samples to further understand participants’
experiences. The primary goal of this research is to demonstrate that, in the yoga group, patients will show
better objective physical performance both patients and caregivers will report greater improvements in QOL
compared to those in the dyadic education group. Secondary goals are to examine improvements in symptom
burden, endocrine and immune dysregulation and symptom management and if these improvements mediate
the physical function and QOL outcomes. Lastly, we examine factors that may moderate interventions effects,
which will inform future studies expanding this program of research. This project represents a major step towards
managing physical performance and QOL in lung cancer patients and their caregivers, a vulnerable yet
understudied population.

Public health relevance
PROJECT NARRATIVE This project will demonstrate the effectiveness of a yoga intervention to improve physical performance, quality of life and symptom burden in patients with lung cancer. Because informal caregiving has been linked to poor quality of life, this intervention study also includes patients’ family caregivers to examine if a dyadic yoga program is more beneficial in regard to improving patient physical performance and patient and caregiver quality of life and symptom burden relative to a dyadic education program.